VTA-NAc GABAergic communication underlying stress-induced reward deficits

Millions of Americans suffer from anhedonia, or deficits in reward-seeking, in the context of psychiatric disorders,
such as major depressive disorder, schizophrenia, and substance use disorders. Stress can both exacerbate
these disorders and directly cause anhedonia. Mice subjected to chronic stress also develop reward-seeking
deficits. However, it remains unclear how stress disrupts reward-seeking. Reward-seeking is a complex process
that includes anticipatory motivation to obtain rewards, an assessment of the hedonic value of rewards, and
learning to associate reward-predicting cues with rewarding outcomes. Communication between the ventral
tegmental area (VTA) and the nucleus accumbens (NAc) plays a central role in these processes. Dopamine (DA)
released from the VTA to the NAc supports components of reward-seeking, including anticipation and learning.
Yet efforts to show that VTA-NAc DA deficits underlie stress-induced anhedonia have yielded mixed results.
Recently, researchers have identified that inhibitory VTA GABA neurons are also key for setting expectations
that both guide reward anticipation and associative learning. We have found that during acute stress, these VTA
GABA neurons induce rhythmic NAc activity and that this activity predicts subsequent transient reductions in
reward-seeking. Moreover, rhythmically stimulating NAc projecting VTA GABA neurons suffices to recapitulate
both stress-induced NAc rhythmic activity and subsequent reward-seeking deficits. These data raise the
possibility that chronic stress causes anhedonia via VTA-NAc GABA activity. Since VTA GABA neurons have
known roles in anticipation and learning, these data also suggest that chronic stress might disrupt encoding of
specific aspects of reward-seeking. This proposal tests these ideas and directly links chronic stress-induced
VTA-NAc GABAergic activity to subsequent deficits in the encoding of reward-seeking. Specific Aim 1 will test
whether two chronic stress disrupts specific aspects of reward-seeking using tasks that assess associative
learning, anticipatory motivation and hedonic valuation and consider mice along the susceptible-resilient
spectrum. Specific Aim 2 will use optogenetics and chronic in vivo multi-site electrophysiology in awake,
behaving mice to test whether VTA-NAc GABAergic activity causes chronic stress-induced anhedonia by
recording the in vivo firing activity of VTA-NAc GABA projections during chronic stress and subsequent reward-
seeking. We will also determine whether chronic optogenetic stimulation of this pathways suffices to induce
persistent anhedonia. Finally, Specific Aim 3 will use pathway-specific chemogenetic blockade to test whether
blocking VTA-NAc GABAergic activity can prevent chronic stress-induced anhedonia. We will also use Cal-Light
(calcium and light-activated gene expression) to express an inhibitory opsin in stress-activated VTA neurons.
This technique will allow us to test whether inhibiting stress-activated neurons during reward-seeking can reverse
the effects of chronic stress. With this approach, we will develop pathway and cell-type specific understanding
of how chronic impairs reward-seeking with the goal of finding novel treatments for anhedonia.

Public health relevance
Millions of Americans suffer from deficits in reward-seeking in the context of psychiatric disorders, such as major depressive disorder, schizophrenia, and substance use disorders. Stress can both exacerbate these disorders and directly cause reward-seeking deficits. In this project, we will use recent discoveries about inhibitory cells within a key reward circuit in the brain (ventral tegmental area to nucleus accumbens) to uncover the mechanism by which stress causes reward-seeking deficits and to discover ways to prevent and reverse these negative effects of stress.